Mechanisms of HIV accessory protein mediated control of NK cell function

PROJECT SUMMARY
Despite their potent innate cytotoxic activity, NK cells are unable to completely control HIV, however, their
depletion enhances acute viremia, and their proliferation during hyperacute infection is associated with better
control of infection, suggesting they do apply immune pressure. In vitro, infected cells that survive NK cell
exposure have higher levels of MHC-I, suggesting that the MHC-Ilow cells are preferentially eliminated due to
“missing self”. However, our preliminary data demonstrates that while genetic ablation of the HIV accessory
protein, Nef, rescues MHC-I surface expression on infected cells, these cells are not completely protected from
killing, suggesting mechanisms beyond “missing self” are driving NK cell stimulation. Indeed, we have
discovered several new NK cell ligands that are differentially regulated with infection. Unexpectedly, we find that
deletion of Vif from HIV enhances MHC-I downregulation and augments NK cell killing in co-culture assays,
suggesting an additional role for Vif in controlling NK cell function. Finally, humanized mice harboring intact NK
cell responses exhibit an enrichment of mutations in Nef’s acidic cluster (the dominant factor controlling MHC-I
surface expression), resulting in enhanced surface expression of MHC-I. This suggests a new mechanism of
viral escape from NK cell responses via changes to accessory protein regulatory elements. The overall
objective of this proposal is to uncover new mechanisms of HIV accessory protein-mediated control of NK cell
function. We hypothesize that while MHC-I remains the dominant regulator of NK cell activity, the virus employs
additional mechanisms to fine tune this “missing self” trigger. Specific Aim #1 will identify new HIV-regulated
NK cell ligands. This includes the testing of HIV clinical isolates from different clades, which exhibit accessory
protein sequence diversity, and characterizing how the NK ligands CEACAM1, ICAM1, HEVM, CD43, CD44,
and CD58 affect innate and ADCC-mediated NK killing. In addition, we will use mass spec to identify natural
cytotoxicity receptor ligands on infected cells that trigger NK cells, and develop a custom CITE-Seq panel with
an expanded repertoire of NK ligand antibodies for use in future clinical studies. Specific Aim #2 will define how
HIV Vif regulates MHC-I and NK cell activation. Using mutated viruses, mRNA, and siRNA, we propose to assess
how the effects of Vif on Nef may contribute to MHC-I regulation. Finally, Specific Aim #3 will characterize the
effects of NK cell pressure on Nef, Vpu, Vpr, and Vif sequence evolution in vivo using humanized mice with an
enhanced NK cell compartment. Mutants will be reconstructed in vitro to characterize the effects on MHC-I and
other NK cell ligands, and NK cell killing. Finally, enriched mutated sequences from the animal studies will be
compared to sequences in the Los Alamos HIV Database to assess their clinical relevance. Together, this work
will provide mechanistic insights into viral immunoevasion mechanisms that directly affect NK cell function, which
may aid the development of NK cell-based therapies for cure strategies, such as blocking accessory protein
function with small molecules.

Public health relevance
PROJECT NARRATIVE Despite their potent killer activity, NK cells are unable to control HIV infection, but the mechanisms responsible for this immunoevasion are unclear. To characterize mechanisms that HIV uses to “escape” NK cell killing, this proposal aims to identify new host factors regulated by the virus that affect NK cell function, assess how different HIV accessory proteins regulate each other, and track the development of mutations in the viral accessory proteins in response to NK cell pressure. These studies will provide insight into the mechanisms that HIV uses to escape NK cell activity, which could aid in the design of HIV cure strategies, including those using HIV antibodies for therapy.